Implementation of BASICS: Matching Effective Strategies to Address Common Barriers

PROJECT SUMMARY/ABSTRACT (DESCRIPTION)
Brief Alcohol Screening and Intervention for College Students (BASICS) is an evidence-based harm-reduction
approach developed in the early 1990’s to address problematic alcohol use among college students. Since then,
there has been a proliferation of trials supporting its efficacy and effectiveness in diverse college populations
and it has become the basis for the majority of current brief motivational interventions with individual-focused
strategies shown to reduce high-risk drinking behavior and/or negative drinking-related consequences. Despite
this, several challenges and research gaps remain in our understanding of potential barriers faced by college
campuses that are currently implementing BASICS. Additionally, it is unclear whether most schools are delivering
BASICS with adherence to its main components and principles or whether adaptations to the intervention are
routinely applied due to feasibility considerations1. The proposed research aims to use a mixed methods
approach to identify factors influencing implementation outlined by the Exploration, Preparation, Implementation,
Sustainment (EPIS)2 framework and the implementation outcomes acceptability, appropriateness, and feasibility
outlined by the Implementation Outcomes Framework3. Recently, the International Town and Gown Association
(ITGA) financed the implementation of BASICS training with 52+ campuses across the United States, which
consists of an intensive brief training model as well as providing technical assistance from BASICS experts
based out of the University of Washington. Leveraging this large-scale implementation, the proposed F31 study
will examine which factors influence successful integration of BASICS within diverse campus environments. This
training grant will also allow the applicant to develop a depth and breadth of knowledge of BASICS and related
evidence based AOD interventions as well as expand and deepen knowledge of implementation science theory,
mixed-methods data collection, evaluation, and analysis methodology. Data collection through surveys and
interviews will allow for a comprehensive understanding of contextual factors that impact implementation of
BASICS. Additionally, the proposed research will identify descriptive characteristics of BASICS implementers
and universities to better understand circumstances under which the intended mode of delivery of the
intervention is likely to be adapted or adhered to. Findings will contribute to the existing literature on brief
interventions for alcohol use on college campuses, offering insights into the complexities of large-scale
implementation efforts. Knowledge generated by this research will inform future efforts to optimize integration of
BASICS and similar programs, ultimately promoting better public health outcomes and improved student well-
being at universities nationwide.

Public health relevance
PROJECT NARRATIVE Brief Alcohol Screening and Intervention for College Students (BASICS) has been shown to be efficacious and effective in diverse settings, however additional research is needed to understand factors that may influence implementation of the intervention with adequate fidelity and sustainability in different contexts. The proposed study will fill an important gap in the literature by providing a foundation of knowledge and strategies for future implementation efforts of brief alcohol interventions on college campuses, providing lessons learned from previous and ongoing implementation attempts that have been successful in adherence to BASICS principles over time and under differing circumstances.